Circadian Clock Disruption and Colorectal Cancer

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) is the third leading cause of cancer-related deaths in the United States. Despite the
advantages of polyp screening for early detection, early-onset CRC incidence is on an alarming rise in young
adults under the age of 50. Though the underlying cause of early-onset CRC remains fully undefined, suspected
risk factors include behavior and lifestyle elements that govern systemic physiology and are under the control of
the circadian clock. Strikingly, epidemiology evidence links deregulation of circadian rhythms through night shift
work with multiple cancer types, including CRC. The circadian clock is the endogenous biological pacemaker
which controls physiological, immune, endocrine, and metabolic processes that operate to maintain organismal
homeostasis within a strict 24-hour period. Several lines of evidence suggest that deregulation of circadian
rhythms results in cancer initiation and progression, yet the precise molecular mechanisms and detailed signaling
pathways have yet to be elucidated. Moreover, in relation to CRC, the crosstalk between the circadian clock and
proliferative, metabolic, and immune pathways in the intestine are not fully elucidated, and more specifically,
how this crosstalk is involved in CRC progression remains unresolved. To address this knowledge gap, we have
generated a genetically engineered mouse model (GEMM) to elucidate the effects of circadian clock disruption
on the intestinal epithelium that drive CRC pathogenesis. Our central hypothesis is that disruption of the circadian
clock aberrantly drives crucial signaling pathways that remodel the immune landscape, promote
immunosuppression, and accelerate CRC. Aim 1 of this proposal will delineate the crosstalk between the
circadian clock and crucial signaling pathways that regulation inflammation in the intestine. Aim 2 will define the
underlying molecular mechanism of how the clock impinges on temporal control of tumor immunity. Aim 3 of this
proposal will define how the circadian clock controls cellular metabolic pathways that could contribute to
immunosuppression. Taken together, our studies have important clinical implications in understanding how
disruption of the biological pacemaker, on the molecular level, alters tumor initiation and disease progression to
accelerate CRC pathogenesis. These findings will provide novel insight and a molecular rationale for approaches
underlying therapeutic targeting of the circadian clock for the treatment of CRC.

Public health relevance
PROJECT NARRATIVE This proposal is aimed at defining how disruption of the circadian clock accelerates critical signaling pathways that govern colorectal cancer progression. We propose that the circadian clock regulates key metabolic and immune axes that are crucial within the intestinal tumor microenvironment to accelerate colorectal cancer. Our molecular studies will provide new insight towards future directions for targeted therapeutic intervention of colorectal cancer that rely on pharmacological modulators of the circadian clock.